A miniaturized neural network enabled nanoplasmonic spectroscopy platform for label-free cancer detection in biofluids

PROJECT SUMMARY/ABSTRACT
State of the art methods for the early detection and monitoring of cancer are either invasive, time-consuming,
expensive, or frequently inaccurate, which hinders the routine screening of at risk-patients to improve survival
rates. The multiplexed detection of oncometabolites circulating in minimally or non-invasive biofluids, such as
saliva, blood plasma, or sweat, could provide significant clinical and economic benefits. Metabolites and related
circulating biomarkers are structurally unique elements with distinctive absorptive fingerprints in the infrared (IR)
portion of the electromagnetic spectrum. Common approaches that provide multiplexed metabolite detection,
such as mass spectrometry (MS), Raman spectroscopy, and Fourier transform infrared (FTIR) spectroscopy,
are expensive and difficult to miniaturize. On the other hand, inexpensive miniaturized electrochemical techniques
lack specificity, sensitivity, ease, and suffer from limited multiplexing. Portable technologies capable of rapid and
accurate diagnostics of early/late-stage cancer are not readily available.
To address this challenge, our multidisciplinary team proposes an innovative Neural Network Enabled Cancer
Spectroscopy (NNECS) liquid biopsy platform based on plasmonic nano-micro electromechanical systems
(NMEMS) to diagnose and monitor early/late-stage head neck cancer (HNC). Instead of targeting individual
metabolites, we propose to process the entire IR spectrum of saliva, blood plasma, and sweat as a biomarker.
Our focus is head and neck cancer (HNC), a highly metabolic disease where stratification of patients according
to better diagnostic information would greatly improve outcomes. Our platform combines IR NMEMS sensors to
accurately detect IR spectral fingerprints with neural network (NN) frameworks to find the appropriate
combinations of spectral bands that will inform the design of highly multiplexed miniaturized biosensor.
We will take a novel, interdisciplinary approach within the framework of five key components: (i) collecting and
analyzing (FTIR, MS, histopathology/imaging) biofluids (saliva, sweat, blood) from a large number of early/late
stage HNC patients and healthy subjects per year; (ii) developing powerful NN architectures and diagnosis tools
for segregating early/late-stage HNC samples from controls, considering IR data streams from each individual
biofluid as well as their potential combinations; (iii) developing a NNECS platform using arrays of plasmonic
NMEMS targeting specific IR bands resolved by ML algorithms; (iv) determining NNECS early/late-stage cancer
detection performance in terms of specificity, sensitivity, and accuracy; and (v) elucidating which metabolites
drive the changes in the IR absorption of cancer biofluids supported by MS. The expected outcome is a
miniaturized, label-free, affordable, and accurate technology able to radically improve the ability to diagnose early-
stage HNC as well as the monitoring of recurrent HNC patients. Moving beyond, NNECS can be adapted for the
diagnosis and monitoring of a wide range of metabolic conditions, including many types of cancer, diabetes, and
heart-diseases.

Public health relevance
Project Narrative State of the art methods for the early detection and monitoring of cancer are either invasive, time-consuming, expensive, or frequently inaccurate, which hinders the routine screening of at risk-patients to improve survival rates. Here, we propose a portable neural network enabled spectroscopy platform to diagnose cancer in patient biofluids (saliva, blood plasma, and sweat). The expected outcome is to deliver a novel point of care liquid biopsy platform to better classify, monitor, and improve diagnostic sensitivity of a broad range of diseases and conditions, with focus on early/late-stage head and neck cancer.